CACHET - Environmental Biomarkers Core

1. ENVIRONMENTAL BIOMARKERS CORE (EBC): ABSTRACT
The overall goal of the Environmental Biomarkers Core (EBC) is to provide bioanalytical services in support of
ChicAgo Center for Health and EnvironmenT (CACHET) members conducting environmental health research at
the University of Chicago (UofC) and University of Illinois at Chicago (UIC). By providing the necessary
experimental expertise to assess a wide range of environmental biomarkers, the EBC directly contributes to
CACHET’s mission to mitigate environmental health inequities within our communities. Toward that end, the
EBC consists of two complimentary Sub-Cores: 1) a mass spectrometry-based Environmental Exposures Sub-
Core that is P30-specific in services and resources available to members, and 2) a Biomarkers of Exposure
Effects and Susceptibility Sub-Core that leverages existing institutional resources at UofC and UIC and
streamlines services to members. The P30-specific Environmental Exposures Sub-Core at UIC will use mass
spectrometry to assess toxic chemicals, heavy metals and metalloids, herbicides, pesticides, perfluoroalkyl
substances, steroids and DNA oxidation products, among others, in both biological and environmental samples.
New assays for environmental compounds will be developed and validated as needed by CACHET investigators.
The Biomarkers of Exposure Effects and Susceptibility Sub-Core will leverage established institutional strengths
in microbiome sequencing, metabolomics, proteomics, genomics, epigenomics and transcriptomics on the two
campuses. Further, bioinformatics support for all CACHET PI-initiated research projects and Facility Core
activities will be provided from established institutional cores at both partner institutions. For all of these services,
CACHET members will enjoy priority access and subsidized rates for environmental health research projects
provided by Center resources and leveraging institutional cost-sharing of intellectual expertise, management
platforms and heavy investments in high-end instrumentation. These combined resources help address the EBC
mission to provide qualitative and quantitative data regarding biomarkers of exposure, disease and therapeutic
responses as well as levels of environmental contaminants in human subjects, model systems and
environmental samples at subsidized rates and with priority access to Center members.